Lung Development and Repair

DESCRIPTION (provided by applicant): This proposal requests support for a Keystone Symposia meeting entitled Lung Development and Repair, organized by Brigid L.M. Hogan, Ross Metzger and Edward E. Morrisey, which will be held in Santa Fe, New Mexico from February 6 - 11, 2011. The lung is a complex three-dimensional organ. Its vital functions depend upon the initial establishment and maintenance of dynamic interactions between multiple tissue types. These include the highly branched system of airway tubes and terminal alveolar sacs, blood and lymphatic vessels, nerves, smooth muscle and fibroblasts, and cells of the immune system. Defects in these interactions underlie many serious respiratory disorders, both in the neonate and adult. The Keystone Symposia meeting on Lung Development and Repair will highlight recent advances in our understanding of the molecular and cellular processes driving the development of the lung and how its organization is maintained over the long term in the adult, as well as how these mechanisms are perturbed in disease. New ideas and approaches will be catalyzed by examples from other organ systems. The meeting will also address a major goal in lung biology: to identify the progenitor cells that mediate tissue regeneration and repair after damage by environmental factors or disease. PUBLIC HEALTH RELEVANCE: Pulmonary disease is one of the leading causes of morbidity and mortality in the Western world. Given its high clinical burden, additional investigation into the basic mechanisms underlying lung development, repair, and regeneration will provide important insight into neonatal and adult lung disease.

Public health relevance
Pulmonary disease is one of the leading causes of morbidity and mortality in the Western world. Given its high clinical burden, additional investigation into the basic mechanisms underlying lung development, repair, and regeneration will provide important insight into neonatal and adult lung disease.